Rutgers Youth Enjoy Science (RUYES) program

Abstract
In alignment with the strategic goals of Rutgers Cancer Institute and NCI, the goal of this
supplement is to enhance an inclusive mentoring environment and promote the value of
diversity, equity, and inclusion at Rutgers Cancer Institute. To achieve this goal, we aim to: 1)
enhance the mentoring skills of students and post-doctoral fellows who serve as peer-mentors at
Rutgers Cancer Institute; and support development of mentee skills required to manage
mentoring relationships to succeed in research training (Mentoring Up); 2) organize oncology
related Science Clubs in middle/high schools by Teacher Mentors; and 3) provide mentored
clinical and research experience to under-represented minority (URM) medical students to
encourage them to pursue oncology careers. Effective mentoring relationships are critical for
supporting mentees' continued professional development and for overcoming barriers to success
particularly for URM trainees. Formal training to improve mentor and mentee skills benefits both
the mentor and mentee. For Aim 1, we will initiate formal peer-mentor and mentee training
programs at Rutgers Cancer Institute. For Science Club Teacher Mentors initiative (Aim 2), we
will establish after-school Science clubs in 4 middle and high schools in school districts with
high percentage of URM students. For Aim 3, the Oncology Physician Training Initiative to
Maximize Diversity (OPTIM), we engage first year URM medical students (from Rutgers Robert
Wood Johnson Medical School (RWJMS)), in clinical shadowing, cancer research and peer
mentoring of trainees in the Rutgers Youth Enjoy Science Program (RUYES). The supplement
supports costs associated with developing inclusive peer-mentor and mentee trainings;
establishing Science Clubs in middle/high schools; and trainee slots for medical students in the
newly established Oncology Physician Training Initiative to Maximize Diversity (OPTIM). This
supplement builds on the parent NCI funded R25 Training Grant (RUYES; 1R25CA247785),
which engages high school science teachers and URM youth in mentored cancer research,
professional development and community outreach activities to build a diverse oncology
workforce.

Public health relevance
Project Narrative The proposed supplement to Rutgers Youth Enjoy Science (RUYES) project is relevant to public health because it will develop a more diverse biomedical, cancer research and healthcare workforce to address cancer health disparities in New Jersey and nationally. The supplement will provide workshops that augment peer mentors and mentees skills to enhance the overall mentoring and training environment at the Rutgers Cancer Institute of New Jersey. It will support Teacher Mentors who will establish Science Clubs in middle and high schools to increase the value of STEM education in the students. This project will also provide research and clinical training to underrepresented medical students to pursue careers in oncology. In addition, the medical students will serve as role models and pee-mentors to RUYES trainees.